EXPLORING THE ROLE OF CHOLESTEROL IN G-PROTEIN-COUPLED RECEPTOR FUNCTION, STABI

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. A MRAC grant in the total amount of 1,344,000 SU time (1,152,000 SUs on Ranger and 192,000 SUs in roaming) is requested to run large-scale Molecular Dynamics (MD) simulations of Rhodopsin, Serotonin (5-HT2AR), and Dopamine (D2R) G-protein coupled receptors (GPCRs) in explicit lipid membrane environments. The proposed calculations will support achieving the specific aims of the Program Project Grant (PPG: 2 P01 DA012923-08, H. Weinstein, PI). The long-term goal of this project is to investigate the role of specific cholesterol-receptor interactions in GPCR functioning, stability, and oligomerization during cell signaling.